Novel Therapeutic Strategies for Suppressing cGAS-STING Pathway in Alzheimer's Disease

Project Summary | Alzheimer's disease (AD) is a neurodegenerative disorder characterized by
neuroinflammation and neuronal death. We recently identified a novel mechanism involving the
upregulation of the AP-1 subunit c-Jun, leading to the decondensation of genomic regions
containing retrotransposable elements (RTEs) and the formation and accumulation of RNA::DNA
hybrids. Our study showed that accumulation of RNA::DNA hybrids activates the cGAS-STING
pathway, leading to programmed cell death through the accumulation of cleaved caspase-3 (CC3)
in various AD cell models, including cerebral organoids (COs). Targeting this RTEs-RNA::DNA
hybrids-STING axis holds, therefore, promise as a therapeutic approach to counteract the
neuroinflammatory response and cell death in AD.
With this proposal, we aim to develop a novel therapeutic strategy for AD by targeting the
activation of the RTEs-RNA::DNA hybrids-STING axis. In aim 1, we will generate intrabodies
directed at neutralizing the RNA::DNA hybrids we reported to be present in CO models of sporadic
AD (SAD) and familial AD (FAD). In aim 2, we will validate the intrabodies’ efficacy in suppressing
cGAS-STING pathway activation in CO models of SAD and FAD. The intrabodies will be delivered
via AAV vector, and the suppression of the cGAS-STING pathway will be assessed via
immunofluorescence and western blot analysis.
This therapeutic strategy could represent a potential breakthrough in treating AD, offering
a precise and targeted approach to address one cause of abnormal cGAS-STING pathway
activation. Importantly, the specificity of the intrabody-based strategy may reduce off-target
effects, enhancing the safety and tolerability of therapeutic interventions. With this proposal, we
seek to advance our understanding of AD pathogenesis and pave the way for the development of
novel precision medicine treatments with the potential to reduce neuroinflammation and cell
death, alleviating the neurodegeneration associated to this disease.

Public health relevance
Novel Therapeutic Strategies for Suppressing cGAS-STING Pathway in Alzheimer's Disease Project Narrative | This research project seeks a new strategy to treat Alzheimer's disease (AD), which affects memory and brain function, by targeting a specific inflammation-causing molecular axis. Our strategy consists of developing nanobodies to target and eliminate harmful accumulating RNA::DNA hybrids that play a role in activating neuroinflammation and causing neuronal death in AD. This research could lead to a breakthrough in AD treatment, ultimately offering safer, more targeted AD treatments.